Geographic Medicine and Emerging Infections

ABSTRACT: This training program in Geographic Medicine and Emerging Infections provides
a multidisciplinary educational program for pre-doctoral students, post-doctoral research fellows
and clinical fellows at the Albert Einstein College of Medicine (Einstein). Our unique program
capitalizes upon the long-standing research and clinical strengths at Einstein to create a
rigorous research program that will expose trainees to research in parasitology, bacteriology,
virology, mycology and clinical infectious diseases. The research program and didactic activities
bring together clinicians and basic scientists to foster an environment of collaborative research
that is essential for modern biomedical research. Trainees are mentored by distinguished faculty
while pursuing translational research projects that focus on global health, international medicine
and emerging infectious diseases. The program provides training in fundamental methods of
basic laboratory research, clinical translational research and epidemiology to create an
integrated view of geographic medicine and emerging pathogens. Trainees are provided with
opportunities to pursue translational research in collaboration with international collaborators in
locations such as Brazil, India, Malawi, Rwanda and South Africa. A dedicated seminar series
and other established educational activities provide the forum for discussion and development
of new initiatives. This training program is grooming the next generation of young scientists and
clinical investigators in the field of Geographic Medicine and Emerging Infections.

Public health relevance
Public Health Narrative: This application is for an educational program at the Albert Einstein College of Medicine for doctoral students and post-doctoral fellows provides training in Geographic Medicine and Emerging Infectious Diseases. This is a critical need as infections can emerge from anywhere in the world and rapidly spread due to the prevalence of international commerce and the ease of international travel.